FASEB Summer Research Conference, Lung Surfactant: Molecular and Cell Biology

[unreadable] DESCRIPTION (provided by applicant): [unreadable] The overall objective of this conference is to provide a forum for the exchange of new and cutting-edge information regarding the basic molecular and cellular biology of fetal lung development and differentiation of surfactant producing cells, mechanisms in the regulation of synthesis, trafficking and secretion of surfactant lipids and proteins. The conference also will emphasize the pathophysiology of the surfactant system, with regard to protein misfolding and disease, lung injury and repair. We believe that this meeting is unique and highly important, because in addition to inviting speakers who are recognized experts in the surfactant field, we have included renowned experts working in different but related areas to provide in-depth information on topics of stem cell biology and organogenesis, protein misfolding, organelle biogenesis and trafficking and host defense. [unreadable] [unreadable] The specific topics covered include: [unreadable] [unreadable] 1. Genetic control of lung development [unreadable] 2. Organelle biogenesis and the pathophysiology that results from structural alterations of surfactant proteins in human lung diseases. [unreadable] 3. Regulation of lung epithelial plasticity, regeneration, and repair. [unreadable] 4. Molecular pathogenesis of human lung diseases associated with abnormal lung development of mutations in the surfactant proteins. [unreadable] 5. Collectins and mucosal host defense. [unreadable] 6. Design of novel surfactant-based therapeutics. [unreadable] [unreadable] [unreadable] [unreadable]